PHS Evaluation Act

The purpose of this Inter-agency Agreement was to carry out the required transfer of funds from NIH/NIGMS to DHHS as per the PHS Act Section 301 and Consolidated Appropriations Act, 2023, Public Law No:117-328.